Exploiting the Mechanobiology of PD-1 for Cancer Immunotherapy

Project Summary Alopecia Areata (AA) is an autoimmune disease affecting ~2% of the world population, especially affecting black women disproportionately, with no cure at the present time. It manifests as inflammatory response of the hair follicles where immune cells, cytotoxic T cells in particular, attack self-tissue, resulting in hair loss. The mechanism underlying this autoimmune reaction is incomplete understood, and the disease-driving antigens recognized by the specific T-cell receptors (TCR) are not known. The objectives of this project are to identify and characterize Alopecia Areata-specific and force sensitive antigen and cognate TCRs. It is widely accepted that the disease is induced by a loss of immune privilege in hair follicles, leading to the loss of immune tolerance of a subpopulation of CD8+ T cells that recognize self-antigens. We hypothesize that the self-antigen peptide-histocompatibility complex (pMHC) interaction with TCR is stronger than those that provide tonic signals for T cell survival but weaker than the pathogenic-pMHC-TCR interactions. The two specific aims are: 1) To identify AA-driving antigens and their cognate TCRs in human and mouse using a newly developed pMHC-tetramer library-stained single-cell sequencing technique. 2) To characterize the force-dependent AA-pMHC-TCR interaction and compare it with self- and pathogenic- pMHC-TCR interactions using the biomembrane force probe technology of the Zhu lab. Completing these aims will pave the way for future studies investigating TCR signaling induced by pMHC, the resulting T-cell activation/function, improved transgenic TCR mouse models for AA, and an eventual cure.

Public health relevance
Project Narrative This project supplement expands upon the parent grant’s goal to exploit the mechanobiology of PD-1 for immunotherapy by proposing to identify a specific TCR clone implicated in an autoimmune disease, to further characterize TCR mechanoregulation by PD-1 in the context of autoimmunity. In particular, the involvement of T cells in Alopecia Areata (sudden loss of hair) will be studied.